TRANSGENIC MODELS--COOPERATION OF C MYC AND GROWTH FACTORS IN TUMORIGENESIS

The oncogene c-myc and transforming growth factor (TGF)-alpha are frequently co-expressed in human cancers suggesting that their interaction may be a critical step in malignant growth. Consistent with this idea, we recently demonstrated in a transgenic mouse model that TGF-alpha dramatically enhances c-myc induced hepatocarcinogenesis. Regulation of cell cycle and apoptosis was investigated during neoplastic development in the liver of c-myc and c-myc/TGF-alpha transgenic mice. Both lines displayed dramatic increases of mitotic and apoptotic rates before the onset of hepatocellular carcinoma (HCC), but only c-myc/TGF-alpha livers showed significant levels of net proliferation (mitosis minus apoptosis). Subsequently, mitosis declined in peritumorous tissues, concomitant with the previously reported induction of TGF-beta-1, whereas c-myc and c-myc/TGF-alpha HCCs maintained mitotic hyperactivity. The c-myc/TGF-alpha HCCs were also characterized by a particularly strong expression of TGF-alpha and very low apoptotic index in contrast to high levels of apoptosis in peritumorous tissues and c-myc HCCs. Cell proliferation in noncancerous and cancerous tissues correlated with a stronger induction of cyclin D1 mRNA and protein in c-myc/TGF-alpha and c-myc HCCs associated with intense pRb hyperphosphorylation. Severe deregulation of G1/S transition was also indicated by the dramatic up-regulation, particularly in the HCCs, of pRb-free E2F1- and E2F2-DP1 transcription factor heterodimers, as assessed by immunoprecipitation and immunohistochemistry. Increased E2F activity during hepatocarcinogenesis was further indicated by the transcriptional induction of putative E2F target genes involved in cell cycle progression, such as cyclin D1, endogenous c-myc, cyclin A, cdc2 and E2F itself. Cdc2 overexpression and the elevated mitotic indices in the HCCs correlated also with induction of cyclin B steady-state levels. The data suggest that co-expression of c-myc and TGF-alpha leads to selective growth advantage for hepatic (pre)neoplastic cells by disrupting the pRb/E2F pathway and by TGF-alpha mediated reduction of apoptosis.